Administrative and Biostatistics

CORE A – PROJECT SUMMARY
Core A is the Administrative center of the entire Program. Core A will provide the essential administrative support
for all of the investigators in each project and core. This includes fiscal management and oversight for all
components of the Program Project; timely reporting of results and milestone reports, organization and
communication of all Program Project meetings and activities, including internal and external advisory meetings,
programmatic seminars, and outreach. Core A also provides Biostatistics support for each project and core,
data analysis and hypothesis testing, biological pathways and network analysis of omics data. The overall goal
of this Core is to facilitate the seamless interaction of projects and cores, communicate scientific and
technological findings, and harmonize interpretation and communication of complex data sets between program
members. The Core A administrative component will ensure compliance with all regulatory and governmental
guidelines, fiscal management, provide scientific leadership, effective communication to all members and
advisors, and an administrative support structure to ensure the coordination of all Program Project activities.

Public health relevance
CORE A – PROJECT NARRATIVE Core A will function as both the Administrative organization unit and Biostatistical support for this Program Project. Core A will provide all Program Members with essential Administrative support for fiscal management and scientific integration, including communication of data, meetings and interactions with advisory committees. Core A will also provide Biostatistics support for all members of the Program. This will include data analysis, statistical design, hypothesis testing, and a centralized environment for data management, quality control, analysis and transfer within the program.